CENTER FOR PERCEPTION AND COMMUNICATION IN CHILDREN

PROJECT SUMMARY/ABSTRACT
No change by the proposed supplement activities for (5P20GM109023-09).

Public health relevance
PROJECT NARRATIVE No change by the proposed supplement activities for (5P20GM109023-09).